Targeting GCNT3 for Pancreatic Cancer

Summary
Pancreatic cancer (PC) has the highest mortality of any cancer, with a 5-year survival rate of less than 10%.
Despite progress in the development of targeted therapies, the survival rate is still unacceptably low. It is,
therefore, important to identify novel therapeutic approaches that could lead to a more effective treatment for
this malignant disease. This proposal explores the novel concept that a core 2 mucin synthesis gene, GCNT3,
regulates PC growth and survival, ascribing a new and critical role to GCNT3. We have shown that GCNT3
is overexpressed in PC patients and contributes to PC pathogenesis, indicating that GCNT3 is a promising
therapeutic target. However, how GCNT3 regulates PC is not clear. Using in silico small molecular docking
simulation approaches, we discovered that talniflumate is a novel inhibitor that selectively binds to GCNT3.
Examining the molecular mechanisms of GCNT3-mediated PC growth, we found that siRNA-mediated
knockdown of GCNT3 or treatment with talniflumate, inhibited xenograft tumors. Talniflumate also reduced
GCNT3 expression, leading to reduced production of mucins in vivo and in vitro, and improved cellular
gemcitabine uptake. Taken together, our findings strongly suggest that targeting mucin biosynthesis through
GCNT3 may improve responsiveness to drug treatment.
We, therefore, hypothesize that aberrant expression of GCNT3 will lead to excessive mucin synthesis
during PC development and cause chemoresistance. Hence, the inhibition of aberrant mucin synthesis is
sufficient to disrupt the barrier properties of the mucin mesh to efficiently increase the access of
chemotherapeutics to target sites. Three independent, yet interrelated, specific aims are proposed to address
this hypothesis. Aim 1: Generate GCNT3-deficient KPC mice and determine whether targeting GCNT3 ablates
the mucin barrier and inhibits PC progression/metastasis by increasing gemcitabine and nab-paclitaxel (NPT)
efficacy. Aim 2: Determine whether combinational therapy of talniflumate plus NPT are effective in treating PC
by a) evaluating the efficacy and dose-response effects of the combination administered in vivo in a clinically
relevant KPC model of spontaneous PC and b) determining mucin disruption and gemcitabine or NPT uptake
in combination-treated tumors. c) We will establish the GCNT3 and NPT levels in tumor tissue and their
correlation with mucin subtypes (Mucs) and PC treatment efficacy via whole genome transcriptome
sequencing and PET imaging. Aim 3: We will investigate the role of GCNT3 in gemcitabine resistance, mucin
overexpression and PC growth. a) For clinical relevance, we will assess the inhibition of human patient-
derived xenografts (PDX) and PC slice cultures by combinational therapy. b) Evaluate the efficacy of
combination against GCNT3 overexpressing human PC PDX tumors in vivo.
Veterans Health Relevance: Pancreatic cancer major health problem and many veterans and their
families suffered from this neoplastic disease. The results obtained from this study will have high impact, since
they will shed light on future development of novel therapeutic strategies for PC. Thus, this proposal is highly
translational in nature

Public health relevance
Project Narrative Pancreatic cancer (PC) has the highest mortality of any cancer, including in US Veterans, with a low 5-year survival rate. Despite progress in the development of targeted therapies, the survival rate remains unacceptably low. It is, therefore, important to identify novel therapeutics for the treatment of pancreatic cancer patients. This proposal is built on the novel concept that pancreatic tumors produce high levels of mucins, which promote the tumor growth and limit the therapeutic effects. We discovered that the Core2 mucin synthesis gene is overexpressed and responsible for various subtypes of mucins. We identified talniflumate as a novel inhibitor of the Core2 gene. In this proposal, we establish talniflumate as the inhibitor of pancreatic tumor growth and the combining of therapeutic drugs, gemcitabine + nab-paclitaxel, may significantly improve therapeutic efficacy. The results obtained from this study will have high impact and be highly translational in nature.